SPORE in Skin Cancer

Project Summary – Overall
This Wistar/UPenn Skin SPORE represents a highly successful and longstanding collaboration. Immune
checkpoint inhibition has revolutionized melanoma therapy to the point where every high-risk melanoma patient
will be treated at some point with these agents. However, many major questions remain on how best to use
these immune therapeutics. Project 1 will address the unmet need to find an effective biomarker to select
patients for single agent versus combination immunotherapy. Many patients start treatment with ipilimumab and
nivolumab, when they may have responded to anti-PD-1 antibody (Ab) alone, exposing these patients
unnecessarily to the toxicity of combination checkpoint inhibition. Project 1 builds on a fundamental discovery
made through our Developmental Research Program (DRP) that exosomal PD-L1 is an immunosuppressive
factor secreted by melanomas. We propose rigorous clinical utility studies designed to demonstrate this blood-
based measurement as a highly sensitive and specific predictive biomarker for anti-PD-1 antibody (Ab)-based
therapy. Project 2 will address a second unmet need for a safer and effective combination regimen that promises
to be effective in anti-PD-1 Ab refractory patients. Based on extensive preclinical data and a new molecular
target in the autophagy pathway, we have developed a clinical trial of combined anti-PD1 Ab and autophagy
inhibition, a new strategy for reprogramming tumor-associated macrophages to enhance the efficacy of T cell
killing. Project 3 fills a major gap in the treatment of early disease by conducting a clinical trial with anti-PD1 Ab
in Stage IIB/C melanoma patients. Besides in-depth characterization of the immune response, the Project’s
preclinical studies will lead to new strategies for enhancing the immune stimulatory capacity of dendritic cells in
the tumor microenvironment. These three highly translational Projects are supported by longstanding Cores that
have a proven track record of adapting to the rapidly changing needs of melanoma and non-melanoma skin
cancer researchers. Each Project was chosen by the current SPORE leadership for its potential for significance,
impact and innovation. Together, they have the potential to advance therapeutically exploitable biological insights
into new, clinically important therapies of patients with melanoma. Funding from the SPORE has provided us
with important advantages, including a mature, collective, translational mindset, an efficiently functioning tumor
bank, and a highly evolved framework of collaboration between The Wistar Institute and UPenn. The SPORE
has allowed us to bolster horizontal and vertical collaborations with academic and industry partners throughout
the world. The Career Enhancement Program and DRP have enabled transition to new leadership, have formed
the three Projects proposed, and have allowed our research to reach into other cancers of the skin including
SCC, CTCL and Merkel Cell carcinoma. These programs will continue to be supported robustly by strong
institutional support from both Wistar and UPenn. Funding of this SPORE will bring new advances from the
bench to the bedside and fulfill our overall mission of improving survival for skin cancer patients.

Public health relevance
Project Narrative – Overall Despite major advances, the death rate from skin cancer remains unacceptably high. In this proposal 3 Projects address the challenges of immunotherapy in melanoma by identifying predictors of response to therapy, novel combinations of drugs designed to enhance response, new approaches to the timing of therapy administration, and the examination of novel tumor microenvironments and their effect on therapy response. This SPORE’s 3 Cores and Developmental Programs are designed to bring together clinical investigators and basic scientists in highly translational efforts to accelerate the pace of therapy for patients suffering from melanoma and other skin cancers, including cutaneous squamous cell carcinoma (cSCC), cutaneous T cell lymphoma (CTCL), or Merkel cell carcinoma.